Natural History Study and Identification of Patient-Centric Clinical Outcome Assessments in TUBB4A-LD (NIH R21)

ABSTRACT
TUBB4A-associated leukodystrophy (TUBB4A-LD) is a rare pediatric hypomyelinating disorder
caused by sporadic mutations in the TUBB4A gene, which encodes β-tubulin 4A (Tubb4A)
protein. Affected individuals experience significant motor development delay, abnormal
movements, ataxia, spasticity, dysarthria, and cognitive deficits. TUBB4A-LD is a life-threatening
diagnosis for which there is currently no treatment or cure. Promising therapies, such as antisense
oligonucleotides (ASO) and in-vivo gene therapy, are nearing pediatric clinical trials, highlighting
the urgent need for foundational tools to design patient-centric trials that are both safe and
capable of evaluating treatment efficacy. Key challenges remain in clinical trial design and include
gaps in (i) understanding the overall disease course, in particular systemic complications (e.g.,
cardiac involvement), and (ii) the lack of validated patient-centric clinical trial endpoints to ensure
safety and measure efficacy in TUBB4A-LD drug candidate trials, respectively. We propose to
address this urgent gap in clinical trial readiness by leveraging our partnership with
disease/outcome experts, caregivers, and advocacy partners in the Global Leukodystrophy
Initiative Clinical Trials Network (GLIA-CTN). We will longitudinally map the systemic
complications of TUBB4A-LD and develop a novel quantitative measure of systemic burden
(TUBB4A-S) (Aim 1). This effort will guide clinical trial readiness by enabling determination of safe
inclusion and exclusion criteria, identification of individuals at-risk of AEs as well as appropriate
assignment of relatedness of AEs to disease. In addition, this work will also inform evidence-
based clinical guidelines for TUBB4A-LD. Disease severity and complexity in TUBB4A-LD
affected individuals will require patient-centric approaches to identify concepts of interest (COI)
most meaningful to patients and families. Our team has already identified patient priorities and
COIs. In Aim 2, we will identify and measure COAs able to capture patient-centric COIs, to define
meaningful changes in COA measures with clear context of use (COU). The approach will be
framed in accordance with guidance from the FDA as measures of health events and COI
important to the patient community. Together, these efforts are expected to establish a sharable
resource to validate clinical trial endpoints applicable to TUBB4A-LD candidate drug trials. Also,
this work will create a knowledge base on systemic complications of TUBB4A-LD to define
standards of care and inform clinical trial design including, trial eligibility, at-risk prediction and
adverse event attribution.

Public health relevance
PROJECT NARRATIVE TUBB4A-related leukodystrophy (TUBB4A-LD) is a rare pediatric hypomyelinating disorder caused by sporadic mutations in the TUBB4A gene, which encodes β-tubulin 4A (Tubb4A) protein. Therapies such as antisense oligonucleotides (ASO) and in-vivo gene therapy, are nearing pediatric clinical trials; however, lack of understanding of overall disease course, in particular systemic complications and validated patient-centric clinical trial endpoints represent significant gaps to clinical trial readiness. The proposed project will leverage the existing Global Leukodystrophy Initiative Clinical Trial Network (GLIA-CTN) infrastructure to longitudinally map the systemic complications of TUBB4A-LD and identify COAs most appropriate to capture COIs important to the patient community.